Building a multi-scale vascular atlas of the mouse lower urinary tract

ABSTRACT
This GUDMAP Atlas project is focused on the lower urinary tract (LUT; bladder and urethra) of male and
female mice. The Specific Aims are to build 3D multiscale anatomical atlases of (1) the mouse LUT
vasculature and (2) the autonomic and sensory innervation of this vasculature. Times of the life cycle from
embryo to adult have been selected to reveal the impact of major changes in organ structure and function
on vascular patterning. The outcomes of Aim 1 will fill a major gap in GUDMAP and the broader literature,
where LUT vascular structures have been under-explored in comparison with LUT muscle wall and
epithelium. The outcomes of Aim 2 will provide a second important dimension to GUDMAP and the
literature, by superimposing on the vascular atlases the closely associated axonal plexuses (sensory and
autonomic) that regulate LUT vascular function. Most of these axon classes do not originate from pelvic
ganglia, so provide to the GUDMAP database new resources that are quite distinct from the existing
knowledge base. In addition to developing new knowledge on the vascular system, the outcomes of the
project will support generation of new hypotheses on LUT function in health and disease.
.

Public health relevance
PROJECT NARRATIVE This project will develop new atlas resources for the research community, to enhance understanding of the vascular system that maintains tissue health within the lower urinary tract. This foundational knowledge base will provide the opportunity to develop new hypotheses on mechanisms of (and solutions for) vascular dysregulation or disruption in clinical conditions (e.g; diabetes, pelvic congestion syndrome).